Admin Core

CORE A: SUMMARY
The administrative core will oversee all administrative, scientific, and budgetary aspects for the
Program Project, as well as, coordinate and document the ongoing meetings of the PPG
Steering Committee and it boards, and facilitate communication among investigators.
Specifically, key responsibilities of the Administrative Core include the following: 1) following
and implementing guidelines for Program Project support, 2) overseeing the scientific progress
of all Projects and Cores, 3) managing all financial and budgetary issues, 4) justifying all
expenditures and negotiating with vendors on supply costs, 5) scheduling and meetings of the
PPG Steering Committee, 6) organizing periodic meetings with Internal and External Advisory
Committees and the PPG Steering Committee, 7 interfacing with Temple University
administration, 8) facilitating the preparation and submission of required NIH/NHLBI annual
reports, 9) assisting in submission of co-authored PPG publications, 8) purchasing supplies for
Projects and Cores, 10) clerical assistance. Dr. Raj Kishore, the Principal Investigator, will be
responsible for the overall coordination, integration, and administration of the Program Project
and will devote 5% effort as director of the administrative core. Dr. Kishore will oversee the
scientific progress of all Projects and Cores and will chair the ongoing meetings of the PPG
Steering Committee as well as all meetings with the Internal and External Advisory
Committees. He will also be responsible for the overall fiscal administration for the Program
Project. Dr. Kishore will have the support of Ms. Dolores Hatch who will serve as Administrative
Manager for this PPG as well as that of Administrative and Grant’s manager for Center of
Translational Medicine and Department of Cardiovascular Sciences at Temple School of
Medicine and other office support staff. Ms. Hatch has tremendous experience in office
management, Grant management and budgeting. The continuous coordination of Program
objectives requires a highly functional administrative Core A to free up researchers and allow
them to focus upon their science in the most productive fashion possible.

Public health relevance
Core A: Narrative This administrative core is essential for the coordination of Program Projects and dissemination of information to the public. The Core serves a vital role in the ongoing success of the Program and is the front line of networking between the multiple facets of the Program.